Differentially expressed genes in male and female DRG during pain and pain-relief; isoform specific cellular expression of RNAs

The objectives of the proposed research include 1) to define the differentially expressed RNA splice isoforms
of ATF3 responsible for the sex-specific differences in pain and pain-relief and develop a model for their
involvement in the associated molecular signaling, and 2) to provide rigorous training to undergraduate
research scholars about pain research. Nerve injury creates a dynamic dialog between glia, infiltrating immune
cells and neurons. In response to the milieu of cytokines, the peripheral neurons become hypersensitive, which
the central nervous system interprets as pain. This environment causes changes in gene expression leading to
chronic hypersensitivity, persisting even after healing. While acute hypersensitivity is an important component
of the nociceptive signaling of injury, disruption of this process can cause protracted or debilitating pain,
leading some patients to opioids for relief, and the possibility of experiencing opioid use disorder. Here, we
propose to develop a more comprehensive understanding of the transcription factors that are differentially
expressed in the rat dorsal root ganglia during neuroinflammation associated with hypersensitivity and pain,
and that are differentially expressed between sexes during pain-relief. Rat neuropathic pain resulting from
surgical chronic constriction of the sciatic nerve, causes hypersensitivity over the same time course and
quantitatively to the same degree in both sexes. However, when treated with a single micro-dose of a
nanotherapeutic containing 0.24 mg/kg of celecoxib, we find that males achieve multi-day pain relief equal to
pre-surgical baseline, while females receiving the same treatment achieve only partial relief. This indicates that
the underlying biology of the neuroinflammatory response that is reacting to the NSAID is different in males as
compared to females. Using a higher single dose of celecoxib per nanodroplet (2.4 mg/kg), we have found that
males and females can achieve the same relief. Under the conditions of equal relief, our NextSeq (Illumina)
and separately Revio Long-Read (PacBio) RNA sequencing of the dorsal root ganglia revealed differential
expression and alternative RNA splicing between the neuroinflammatory state and relief for males versus
females. This collection of sexually dimorphic and differentially expressed genes includes genes of the
Druggable Proteome. The primary target of our proposed analysis is ATF3, a cyclic AMP Response Element
Binding protein (CREB) transcription factor responsive to nerve injury and nerve regeneration. Research by
others show that ATF3 has distinct functions depending on the protein isoform produced by different mRNA
splice variants. With teams of undergraduate research scholars, we propose to explore the cell specific and
splice isoform specific expression of Atf3 mRNAs in the neurons, glia and infiltrating immune cells during pain,
during pain relief and during tissue regeneration through the use of multi-color fluorescent in situ hybridization
for both males and females. Other candidate genes that we will study include the transcription factors Fos and
Nr1d1, and the dynamin-like GTPase MX1, each exhibiting sexually dimorphic and differential expression.

Public health relevance
Pain and chronic pain contribute to human suffering, in part, because pain is still poorly understood at the cellular and molecular level due to the complex interplay of neurons, glia and immune cells. Analysis of dorsal root ganglia differentially expressed RNAs responding to pain and pain-relief and between males and females has identified sex specific regulated biological pathways that need to be explored at the cellular level. Together with teams of undergraduate researchers, we will use multi-color fluorescent single molecule in situ hybridization with exon-specific probes and other fluorescent stains to establish which RNA splice isoform of a gene is expressed in particular cells that contribute to the sex differences in pain and pain-relief.